Yale Clinical and Translational Science Award

Contact PD/PI: Smith, Brian Richard
1. Overall: Project Summary
The Yale Center for Clinical Investigation (YCCI) was created in 2005 to advance Yale's clinical research
mission. One year later, YCCI became the home of the Yale CTSA. At YCCIs inception, Yale was a national
leader in T0-T2 translational research, basic/translational science training, and it supported distinctive
fellowship programs such as the Robert Wood Johnson Clinical Scholars Program. Since then, the CTSA has
had a transformative impact linking diverse components of the Yale community in T1-T4 research, providing
the central infrastructure for the effective conduct of ethical, innovative, rigorous, and reproducible research,
and in training the next generation of research leaders. By any metric of scale, breadth, quality, and impact,
both the CTSA's research enterprise and its educational mission have been enormously successful for Yale.
This renewal application does not simply seek to maintain excellence, but to enable YCCI to drive the
continued transformation of the Yale T1-T4 translational research mission and its predoctoral and postdoctoral
training mission and to promote collaboration across CTSA hubs. First, it will support informatics and
computational advances that drive the emergence of a learning health system. In so doing, it will draw on the
Yale New Haven Health System, a six-hospital 2,681-bed consortium that provides more than 2.4 million
outpatient visits from patients from upper Westchester county, throughout Connecticut, and southern Rhode
Island. It will also prepare young scientists to draw on this infrastructure to conduct research that influences the
future of healthcare. Second, it will support technological and scientific advances in areas that will support the
emergence of personalized healthcare, including multi-omics and imaging. YCCI will provide pilot grant support
and training to foster the development of research careers and research teams that can deepen our insights
into pathophysiology and build toward personalized treatments. Third, it will engage a broader and more
diverse group of faculty, trainees, and community representatives to collaborate in the mission of addressing
healthcare disparities that constitute a major burden on patients, their families, and on public health. To
support this mission, YCCI will also foster the development of careers in community-based research from a
diverse group of young investigators and enhance the overall clinical research workforce.

Public health relevance
Yale Center for Clinical Investigation (YCCI) has been a leader and strong partner with other CTSA hubs in research democratization to diverse populations, enhancement of the electronic health record to promote translational science, and leveraging the broad expanse of Yale University's outstanding T1 to T4 multi-School scientific environment with the clinical strength of Yale New Haven Health System to create a learning health system that reaches into communities. YCCI will work with other CTSAs to foster the further growth of multidisciplinary team science, develop innovative collaborative precision-health based strategies for disease prevention, diagnostics, and therapeutics, and implement to obtain real-world beneficial results for the benefit of all populations in the learning health system.